Identifying the cells and circuits driving stimulus-independent activity throughout the developing Drosophila brain

ABSTRACT
The developing brain becomes active before it is ready to receive sensory input. Such stimulus-independent
developmental activity was originally described and characterized in the visual system over three thirty years
ago. Since then, the phenomenon has been observed and studied in many additional areas of the brain, including
other sensory systems as well as in the thalamus and cortex. Where tested, altering developmental activity leads
to disorganization of neuronal connections. While its role in instructing wiring fidelity has received significant
attention, two important questions about developmental activity remain largely unaddressed: First, is the activity
is coordinated across disparate brain regions? And, secondly, what is the significance of developmental activity
to shaping behavior, and more specifically, how does it contribute to the maturation of a healthy nervous system?
Understanding brain development is a significant scientific challenge with direct relevance to human health.
Studies into the causes of neurodevelopmental disorders rightly cast a wide net, covering progressive stages of
neural development from proliferation to morphogenesis to synaptogenesis. Notably, developmental activity—
as an evolutionarily conserved process—remains a blind spot, mostly due to the challenges of working with the
mammalian model: both in utero development and the daunting size and complexity, make the requisite
exploratory studies prohibitively costly.
The fruit fly brain also has developmental activity comparable to that seen in mammals. Patterned, Stimulus-
Independent Neural Activity (PSINA, ‘see-nah’) engages the whole brain in highly structured and stereotyped
activity, providing neurons their first opportunity to communicate across previously inaccessible spatiotemporal
scales. The fly, with its approachably complex brain and an ever-expanding molecular-genetic toolkit, is at the
forefront of cellular, systems, and behavioral neuroscience research. The discovery of PSINA introduced this
powerful fly model to complement mammalian studies into developmental activity.
Recently, our lab reported that a population of ~2,000 neurons, genetically defined by their expression of the
cation channel Trpγ, is critical to coordinating PSINA across the brain. We know that a much smaller subset of
this population is directly involved in PSINA. In my first Aim, I will use a recently developed molecular-genetic
approach to functionally fractionate Trpγ+ population down to individual cells. In the process, I will learn how the
circuitry of PSINA is organized to produce its distinct spatiotemporal structure. Further insights into the biology
of PSINA will come from my second Aim, where I will ask how a neuropeptide signaling pathway acts through
specific neurons to shape the activity. With the successful completion of this project, we will gain the experimental
control to explore how critical brain functions, from sensory processing to sleep and learning-and-memory, are
shaped by developmental activity. I expect that the discovery science I carry out in fly will motivate studies in the
mammalian system to address the relevance of developmental activity to the assembly of a healthy brain.

Public health relevance
Project Narrative The developing brain becomes active before sense organs and their connections to the brain are mature enough to provide input. Even though this spontaneous developmental activity happens in many parts of the brain, outside of very specialized cases, we do not know how it helps in building a healthy, functioning nervous system, or whether changes in the activity leads to neurodevelopmental disorders. Using the much simpler brain of the fruit fly, I will look for the nerve cells that bring about developmental activity so that we can change how they work and begin to study the effects of altering the activity on behaviors such as sleep and learning-and-memory.